UC Davis CTSC TL1 Administrative Supplement to Recognize Excellence in Diversity, Equity, Inclusion, and Accessibility Mentorship

PROJECT SUMMARY / ABSTRACT
The UC Davis Clinical and Translational Science Center (CTSC) NRSA Training Core (TL1) is committed to
supporting trainee diversity and providing crucial training resources in the field of equity and diversity. The
overriding objectives are to facilitate individualized training pathways for a diverse workforce that crosses
disciplinary boundaries and provide a pipeline of trainees to engage in academic, clinical, entrepreneurial,
government, or industry-related opportunities. To continue our strong trajectory and build on a successful
foundation, the specific goals of the TL1 in the next funding period include: (1) Provide a flexible
interdisciplinary curriculum tailored to TL1 trainees that advance translational and clinical research core
competencies; and (2) Supplement successful pathways to increase the diversity of the translational science
research workforce. The goal of this Administrative Supplement to Recognize Excellence in Diversity, Equity,
Inclusion, and Accessibility (DEIA) Mentorship is to expand the UC Davis TL1 program by including additional
scholars from under-represented backgrounds to launch their translational research careers. We have
streamlined our selection process to provide additional coaching to an increasingly diverse trainee population
and we are offering enhanced training opportunities which include Asking Different Questions training modules,
Healthcare Delivery Science, and one-on-one career coaching. The proposed additional trainees (one medical
student and two graduate students) will have access to the entire educational offer provided by the TL1
program, structured in one year for the medical student and two years for the graduate students, into which
principles of equity have been thoughtfully incorporated.

Public health relevance
NARRATIVE The UC Davis Clinical and Translational Science Center (CTSC) NRSA Training Core (TL1) is committed to diversity. Our program has a large pool of diverse applicants and we provide established and enhanced training opportunities to ensure rigorous translational research training and integration of values of justice and equity into scientific practices. The proposed supplement will support the enrollment of additional predoctoral scholars who will have access to all TL1 educational experiences including a new coaching program characterized by one-on-one trainee-centered approach to career mentoring.